Optimizing Dimensions of Reinforcement to Enhance Behavioral Interventions

Project Summary/Abstract
Over 2 million people in the United States with intellectual and developmental disabilities (IDD) engage in
some form of severe problem behavior (SPB; self-injury, aggression; Crocker et al., 2006). Behavioral
treatments for SPB are predicated on identifying effective reinforcers that increase appropriate behavior and
maintain low levels of SPB. Unfortunately, the reinforcing efficacy of putative reinforcers identified using typical
clinical approaches often diminish over time or are not suitable for varied real-world application (e.g., Roane et
al., 1998). There are important dimensions of reinforcement that have been discovered in basic behavioral
research that have not yet been translated into applied practice. Such dimensions move beyond simple
measures of relative reinforcing value typically assayed in clinical domains via stimulus preference
assessments (Fisher et al., 1992) and related methodologies (e.g.; Lee et al., 2008; Leon et al., 2021;
Hagopian et al., 2020), and instead focus on the conditions under which, and how quickly, the effects of
reinforcement are established, maximized, and diminished. These dimensions of reinforcement interact with
schedule arrangements and response requirements to yield patterns of schedule performance that ultimately
determine the conditional effectiveness of a given reinforcer on which behavioral interventions may be
predicated. We posit that a multivariate analysis of these dimensions can enhance our understanding of the
stimulus properties of various reinforcers and operant contingencies used within behavioral interventions for
SPB. This may allow practitioners to disentangle relative reinforcer value from variables related to
sensorimotor performance and changes in motivation related to time, satiation, and other factors. Based on our
recent research findings, pilot assessment data, and clinical experience, this proposal describes an enhanced
methodology leveraging a quantitative model of schedule performance (Mathematical Principles of
Reinforcement; Killeen, 1994) to identify effective and durable reinforcers for use within behavioral
interventions using a translational-treatment approach. In addition to the practical benefits of identifying more
effective and durable reinforcers, this work will also advance knowledge on the underpinnings of response
strength and behavioral persistence of schedule-controlled behavior, which will have scientific value. Using a
translational-treatment approach, we will seek to identify (1) specific schedule arrangements that maximize
responding (which directly impacts interventions predicated on response competition) and (2) reinforcers that
are associated with minimal resurgence (i.e., the recurrence of a previously eliminated response when the
reinforcement conditions for an alternative response are worsened) following reinforcement omission errors.

Public health relevance
Project Narrative Severe problem behavior (e.g., aggression, self-injury) among individuals with intellectual and developmental disabilities can greatly impair functioning, produce injury, and lead to placement in restrictive settings. Behavior-analytic treatments, which are the current gold standard for reducing severe problem behavior in this population, are predicated on identifying effective and durable reinforcers for use within behavioral interventions. The current proposal will examine a novel method for identifying reinforcers to enhance behavioral interventions by making them more effective and durable in the face of common treatment challenges.